Assessing completeness and accuracy of the EHRs harbored at BigMouth Dental Data Repository

This proposed application will focus on exploring new methods and strategies to improve the usability of
Electronic Health Record (EHR) data for the purpose of oral health research, dental education and patient
care. The research will assess the data quality dimensions at group-level (faculty vs. student) and at institution-
level (across the nine dental school sites). The two quality dimensions will be –completeness and accuracy of
the EHR data stored in the BigMouth dental data repository for the years 2017-2019. This project will analyze
the completeness by assessing the granular components - demographics, dental history, behavioral attributes,
and health history attributes inputted by the student and faculty providers for missing data. These granular
components will be measured across variable, time and patient. Patterns of missing data will be evaluated
using multiple imputation. The accuracy of the data will be measured by comparing the odontogram to the
corresponding radiographic image. All the analysis will be done using the EHR data from the BigMouth dental
data repository that contains clinical data from nine dental schools. This research will facilitate the importance
of using EHR data in oral health research; understand the importance of data validation and reliability, and
improving patient care outcomes within the dental schools that contribute to this repository.

Public health relevance
The proposed research project will analyze the quality of data stored in the BigMouth dental data repository. This data repository is produced by the clinical data deposited by nine dental schools in the U.S. The focus of this application is to analyze two data quality dimensions—accuracy and completeness from 2017-2019 to increase the reliability of EHR to advance oral health research. High quality EHR can be a crucial component for patient care delivery, and decision making in treatment planning, clinical and health disparities research, evidence-based dental education, and several other aspects of patient care delivery and research. It is also an indispensable vehicle for improving training of future dental providers. This project will evaluate two data quality dimensions—accuracy and completeness at group-level (faculty-level and student-level) and at the institutional-level. The results can improve the usability of the EHR data stored in the BigMouth Dental Data Repository for research, education, and patient care.